Mentoring Vision Research In Oklahoma

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Will enable the employment of four new personnel, including two junior faculty who will be mentored toward independent research careers.